SIV TRANSMISSION BY LOW-DOSE VAGINAL INOCULATION OF RHESUS MACAQUES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Low dose vaginal challenge with SIVmac251 results in infection by a single founder virus in a majority of animals and evidence for transient viremia.